Role of smoking in severe influenza virus pneumonia

The prevalence of smoking habits is much higher in US veterans (21.6%) than that in the general
population (13.7%). Individuals who smoke are more susceptible to influenza virus infection (Flu),
which often progresses to severe acute lung injury (ALI), results in high morbidity and mortality
than nonsmokers. However, the immune mechanisms by which cigarette smoke (CS) enhances
Flu severity need to be better defined, and thus effective therapies are limited. To investigate this,
we have established a two-hit model of 4-week CS exposure and subsequent intranasal influenza
A virus (IAV)-infection (CS+Flu). In this model, by using intravital (in vivo) multi-photon-excitation
fluorescence microscopy, for the first time, we observe that prior CS exposure induces
hyperactivation of innate immune responses against Flu as evidenced by a significant increase in
platelet-rich neutrophil-platelet aggregates (NPAs) and circulating neutrophil extracellular traps
(NETs), leading to more profound weight loss and severe ALI relative to Flu alone. Our preliminary
findings revealed that two-hit (CS+Flu) induces “platelet-rich” NPA formation and uniquely
upregulates TLR7 (toll-like receptor 7, a sensor of single-stranded RNA of IAV) and caspase-11
(the effector of non-canonical inflammasome pathway) in circulating platelets of mice. Further,
circulating neutrophils isolated from mice exposed to CS+Flu uniquely expressed the active forms
of both caspase-11 and gastermin-D (GSDMD-NT), an executor of pyroptosis. Additionally,
coagulation (tissue factor [TF] expression and fibrin deposition) was increased in the lung of
CS+Flu relative to RA+Flu mice. These findings form the basis for our overarching hypothesis
that prior CS exposure exacerbates Flu-induced ALI through pulmonary microvascular occlusion
by platelet caspase-11 mediated platelet-rich NPAs, leading to GSDMD-mediated NETs
generation, followed by fibrin deposition in the lung. This proposed study will be the first to
introduce a novel paradigm that occlusion of lung microvasculature by platelet-rich NPAs
promotes CS-induced Flu severity and potentially identify a new therapeutic target – platelet-
neutrophil caspase signaling to promote Flu-induced thrombo-inflammation and severe ALI.

Public health relevance
PROJECT NARRATIVE. Cigarette smoke (CS) contributes to the development of severe influenza virus pneumonia. However, innate immune mechanisms by which CS exacerbates flu-induced lung injury are not well understood. The proposed study will introduce a novel paradigm that occlusion of lung microvasculature by neutrophil-platelet aggregates promotes CS-induced flu severity and potentially identify a new therapeutic target in the platelet-neutrophil signaling.